Using Smartphone Personal Assistant Technology to Improve Prospective Memory in Alzheimer's Disease

Abstract: Alzheimer’s disease is a debilitating condition for patients and their caregivers that have hallmark cognitive symptoms (e.g., memory loss) as well as a profound impact on non-­cognitive symptoms (e.g., quality of life). Researchers and clinicians are learning that a specific type of memory, called prospective memory, may be particularly affected in mild Alzheimer’s disease. Prospective memory is memory for future intentions, goals, and chores, and the loss of the neurocognitive processes supporting prospective memory may reduce independent functioning (e.g., medication adherence). We propose a technology-­based intervention study to assist participants with their daily prospective memory tasks. Participants with mild Alzheimer’s disease will be trained to use a smartphone for four weeks. We will measure the acceptability, usability, and overall user experience of the smartphone in participants with mild Alzheimer’s disease. Furthermore, we will test whether the personal assistant feature of smartphone can assist participants with daily prospective memory tasks. In one group, participants will train to use the personal assistant reminder system, which reminds participants of their goals, tasks, and chores at the appropriate time or GPS-­defined location. Our comparison group will also carry a smartphone but will train to use a cognitive strategy in which they verbalize external cues to remind them to perform their goals, tasks, and chores. We predict that participants with mild Alzheimer’s disease who use the personal assistant reminder system will show objective improvements on a diversity of theory-­based, experimenter-­provided prospective memory tasks. Furthermore, we propose that to the extent that prospective memory is improved, perceptions of quality of life will also improve. This research will inform whether smartphone technology can be used to reduce memory burden and improve daily, independent functioning in participants with mild Alzheimer’s disease.

Public health relevance
Narrative By providing reminders at specific times and locations, smartphones have the capacity to relieve burdens on memory. The goal of this research is to investigate whether smartphones can improve daily memory functioning (medication adherence, remembering chores, etc.) in patients with cognitive impairment.